Utilizing opioid receptor expression to identify the neurons and molecules responsible for opioid respiratory depression and basal breathing.

Project Summary/Abstract
No changes from Parent award.

Public health relevance
Project Narrative No changes from Parent award.